CD10-bound Exosomes from IFP-MSC Degrade Substance P Controlling OA Inflammation and Pain

PROJECT SUMMARY
Osteoarthritis (OA) ‘clinical phenotypes’ have similar clinical end-points (pain, stiffness, joint damage,
etc.), and a common activation of local inflammatory/immune cascades. Synovitis/infrapatellar fat pad (IFP)
fibrosis participate in OA, with Substance P (SP) neuropeptide mediating pain perception and local
immune/inflammatory responses. IFP-derived Mesenchymal Stem Cells (IFP-MSC) enriched for CD10 induce
SP degradation in vitro and in vivo significantly reversing synovitis/IFP fibrosis and attenuating articular cartilage
degradation. IFP-MSC supernatant comparably degrades SP via the release of CD10-bound exosomes
extracellular microvesicles. This project aims at generating exosomes with varying CD10 levels (Unfractionated-
, CD10High-, CD10Low-, and siCD10-bound exosomes) from immunophenotypically sorted IFP-MSC under
regulatory-compliant practices. The generated exosomes groups will be tested for their SP degradation effects
in vitro and in vivo, and their therapeutic effects to simultaneously target synovitis/IFP fibrosis together with
attenuation of joint pain and AC degradation in vivo.

Public health relevance
Project Narrative Osteoarthritis (OA) is a debilitating, progressive condition that constitutes a significant public health problem as its incidence is continuously growing in the general population, to whom only palliative and suboptimal therapies can be offered. In this proposal, we are generating and testing the therapeutic activity in OA of a novel alternative based on microvesicles released by stem cells, after processing them with protocols that enhance their capacity to modulate the local immune system and attenuate inflammation/AC degradation within the joint. From a translational standpoint, we envision a reformulation in the therapeutic approach for OA in humans, with solutions that target key triggering molecules and events in a reproducible, safe and efficient manner.